Research Oncology Training Grant

DESCRIPTION (provided by applicant): The primary goal of this Training Program is to prepare Predoctoral and Postdoctoral Fellows for investigative careers in Cancer Research. The Predoctoral Training Program provides a forum within the current Biomedical Sciences Training Program for graduate training at CWRU that emphasizes Cancer Research. Trainees will have intensive research experience under the close guidance of a full-time faculty member in the disciplines of Pharmacology, Molecular Biology, Biochemistry, Physiology and Biophysics, Immunology or Cell Biology. The Postdoctoral Training Program integrates the training of basic scientists (PhD) and physician scientists (M.D. or M.D./Ph.D.) under the direction of a select faculty from the Comprehensive Cancer Center at Case Western Reserve University and University Hospitals of Cleveland who bridge traditional departmental boundaries to apply multidisciplinary approaches to fundamental problems in oncology. For Postdoctoral Trainees, formal didactic training will include required participation in a scientific ethics course, "On Being a Professional Scientist: Ethics and Biomedical Research", the weekly Cancer Center Seminar series, and the weekly Cancer Biology and Cancer Genetics Journal Club. Both predoctoral and postdoctoral trainees make formal presentations of their research at two interdisciplinary Cancer Center sponsored events: the monthly Cancer Training Meeting and the annual Cancer Center Retreat. All Trainees will be expected to attend formal basic science seminars relevant to their area of study. M.D. Postdoctoral Trainees, without previous research training, will be encouraged to attend graduate level basic science courses as needed to bring their level of knowledge up to that of Ph.D. or M.D./Ph.D. trainees. Predoctoral Trainees will participate in the Core Academic Program of the Biomedical Sciences Training Program within the first semester of training, then in the remaining period of training participate in thesis research with a Research Oncology Training Program faculty mentor, with additional didactic course work focused on cancer. The Training Program will be governed by a Steering Committee charged with responsibility for (i) active recruitment of trainees, with an emphasis on women and underrepresented minorities; (ii) selection of high caliber candidates who are fully committed to Cancer Research careers; (iii) tracking the progress of trainees according to specified criteria and standards; (iv) evaluating the mentorship provided by individual faculty; and (v) tracking the success of trainees who have completed the training program.